Cancer Center Administration

ADMINISTRATION: PROJECT SUMMARY
Administration, led by the Associate Director for Administration and Planning (ADAP), Sharon Levy, supports achieving the Georgetown Lombardi Comprehensive Cancer Center (LCCC) vision through executing and tracking strategic planning, fostering innovative collaborative science, driving career development, and ensuring alignment with catchment area needs. Administration, encompassing 16 direct and 8 secondary FTEs, provides support to the Consortium comprising Georgetown University (GU), based in Washington, DC and the John Theurer Cancer Center (JTCC) of Hackensack Meridian Health (HMH), which is headquartered in NJ. Supporting three Research Programs, nine Shared Resources, and 109 members focused on basic, translational, clinical, and population-based cancer research, Administration manages an annual operating budget of $73.3M that includes $21.9M (ADC) in cancer-relevant, peer-reviewed funding, $16.9M ADC in other grants and contracts, and an annual institutional budget of $34.5M as well as a separate $129.82M in institutional investments from GU, MedStar Health (MH), and HMH for Consortium-related activities. Institutional investments are deployed at the Director’s discretion, ensuring that investments are aligned with LCCC’s strategic plan. Levy assumed leadership of the administrative team in October 2020 when she was promoted from CCSG Administrator to ADAP. Under Levy’s guidance, Administration has considerably expanded its role in overseeing consortium administrative operations at all sites. This required development and implementation of robust processes to foster science across the DC and NJ campuses including revised membership criteria and technology investments to build out infrastructure across the Consortium (OnCore, Idea Elan, Shiny App grants database). Administration has fostered research program restructuring, development and expansion of Community Outreach and Engagement, Cancer Research Training and Education, and clinical research infrastructure. These changes have resulted in a 61% increase in cancer-relevant, peer-reviewed funding, the recruitment and onboarding of 30 peer-review–funded faculty members, expansion of shared resource usage across the consortium with a high satisfaction rate, and a new 2021-2026 Strategic Plan.